Yale Clinical Neuroscientist Training Program

Abstract This proposal describes the Yale Clinical Neuroscientist Training Program (CNSTP), the research education program for Neurology residents at the Yale School of Medicine. This program integrates the vast array of innovative and exciting collaborative research opportunities available within the School of Medicine with a select group of outstanding, dedicated mentors in neuroscience. These mentors were selected on the basis of significant research accomplishments, a consistent record of independent funding, and an exceptional track record in the mentoring of clinician scientists. This group of mentors, when combined with the vibrant neuroscience community at Yale, a track record of training distinguished clinicians, rich core facilities and resources, makes the CNSTP at Yale a unique program that develops the careers of physician-scientists. This program has an established track record of nurturing careers of neurology residents towards career development awards. This renewal application leverages these existing strengths and strives to innovate strategies for retention and promotion of outstanding future physician-scientists and seeks continued NINDS funding to buttress these efforts.

Public health relevance
Narrative Nationally, there is a pressing need for highly trained clinician-scientists working towards understanding basic mechanisms of diseases of the brain. The Yale Clinical Neuroscientist Training Program (CNSTP) is uniquely designed to provide the research tools, clinical skills, and mentorship required in the transition from resident to independent faculty member. Many residents in Neurology come to Yale with an extensive research background and they complete residency as highly skilled neurologists equipped with state-of-the-art knowledge of neuroscience and neurological disease. They also leave residency with a keen grasp of the most pressing unanswered questions in nervous system disease. This program will allow them to seamlessly integrate research and clinical training using the vast educational and research resources at Yale. Trainees will be fostered to become creative and innovative scientists, successfully obtain a mentored career development award and ultimately lead an independently funded research laboratory. We are confident that these carefully trained and nurtured individuals will develop into leaders in academic medicine.